The inward rectifier potassium channel Kir7.1 is at the center of energy homeostasis regulation

Obesity is a metabolic disorder of pandemic incidence in developing countries and the United States. The
development of new therapeutic interventions to help mitigate this disease is a significant need in the clinic and
for public health. Gaining insight into the role of specific brain areas in eating behavior will lead to the discovery
of treatable targets for which drugs can be developed to support metabolic disorder treatments. In support of
this proposal, we present new data showing that central and peripheral administration of a specific inward
rectifier potassium channel Kir7.1 blocker, ML418, produces a robust anorexigenic effect. These results reveal
a new target in the satiety pathway that has not been previously studied. The current application is centered on
the hypothesis that Kir7.1 regulates the sensitivity setpoint of the hypothalamic nuclei involved in energy
hemostasis. We propose to employ a TRAP (targeted recombination in active populations) approach for
accessing and controlling target-sensitive neural circuitry that becomes active after the pharmacological
inhibition of Kir7.1 with ML418. The first aim will identify the Kir7.1 responsive neurons, and it will validate the
participation of these neurons in determining feeding behaviors by challenging the activated centers with a
chemogenetic approach. In the second aim, we will identify hypothalamic circuitry associated with Kir7.1-
activated neurons that regulate energy homeostasis. This proposal presents Kir7.1 as a novel regulator of
energy homeostasis and a potential target for developing novel therapeutic approaches against obesity. More
generally, this work will establish a fundamental platform for basic and clinical research to treat obesity and
eating disorders.

Public health relevance
Public Health Relevance Obesity is a major risk factor for type II diabetes and accounts for a significant proportion of healthcare costs in the United States and other developed countries. Identifying accessible therapeutic targets is key to searching for treatments for this metabolic disorder. In this proposal, we will investigate the fine regulation of the sensitivity of the brain regions regulating energy balance to drugs with limited use in the clinic by a novel target that may represent a safe and effective way to treat obesity.